Elucidating spatiotemporal dynamics of nascent extracellular matrix in response to platinum treatment in ovarian cancer

PROJECT SUMMARY
High-grade serous ovarian carcinoma (HGSC) is the most common type of ovarian cancer and has the 3rd
highest mortality-to-incidence ratio of all cancers. Even with resection and aggressive platinum-based
chemotherapy treatment, tumor recurrence occurs in 70% of patients, as a result of aberrant extracellular matrix
(ECM) production leading to chemotherapy resistance. While the unidirectional effects of a dysregulated ECM
composition and structure are well documented to contribute to cancer’s ability to resist treatment, knowledge
on the effect of chemotherapy on spatial and temporal changes of the ECM remains limited. A main reason for
this limitation is the lack of technologies that can track spatiotemporal dynamics of newly synthesized ECM in
response to treatment in a biologically relevant yet controlled manner. In studies leading to this application, we
have optimized platforms combining biomimetic tissue engineered cancer co-cultures and metabolic labeling
allowing to track newly synthesized ECM dynamics in response to treatment and further implicate
mechanotransduction signaling with the dysregulated ECM. Our translational approach includes well annotated
and characterized HGSC cell lines and patient-derived xenograft (PDX) lines, as well as primary HGSC and PDX
tumor biopsies. We will utilize innovative engineering approaches, metabolic labeling of newly synthesized
proteins and state-of-the-art super resolution confocal imaging, proteomics from enriched newly synthesized
proteins, machine-learning image analysis, flow cytometry, biomechanical characterization, and
immunohistochemistry analysis to test our hypothesis. Specific aims are to identify platinum-induced
spatiotemporal dynamics of newly synthesized ECM, determine how platinum-induced alterations in cell-ECM
mechanotransduction relate to HGSC chemoresistance, and elucidate how ECM dynamics differ between
platinum sensitive and platinum resistant HGSC tumors. Through these studies, we expect to have an important
positive impact by opening new horizons for development of more efficacious ECM-targeted agents to mitigate
HGSC chemoresistance, monitor treatment response, and ultimately improving chemotherapy effectiveness and
mitigating chemoresistance.

Public health relevance
PROJECT NARRATIVE Dysregulation of the extracellular matrix (ECM) composition critically contributes to ovarian cancer’s ability to resist treatment. While this unidirectional relationship is well elucidated, it largely remains to be determined if chemotherapy alters newly synthesized ECM further aggravating chemoresistance. Using tissue engineering and metabolic labeling approaches we will track spatiotemporal changes of ECM in response to treatment to directly apply significant insights to women suffering this particularly deadly form of cancer.